Core A: Modeling Core

PROJECT SUMMARY/ABSTRACT – MODELING CORE
The Modeling Core forms a foundation for the P01 application by providing critical resources including unique
types of specimens and services to all three projects, to support the overarching goals of identifying the molecular
drivers of prostate cancer (PC) and biomarker development. The performance of translational research
mandates that investigators have ready access to well-characterized and relevant biological models. To
accomplish the objectives of the Core, to support the P01 Projects, we designed three Specific Aims:
Specific Aim 1. Maintain and distribute patient-derived xenograft (PDX) models and cell lines, and run
preclinical studies. The Modeling Core will provide a unique set of metastatic castrate resistant prostate cancer
(mCRPC) LuCaP patient derived xenograft (PDX) models that represent the heterogeneity observed in patients.
The Modeling Core will also perform pre-clinical studies using these resources where appropriate for the Project
goals.
Specific Aim 2. Model interactions between PC and metastatic sites using advanced microphysiological
systems (MPS). MPS are populated entirely with human cells and recreate the architecture of the tumor
(vasculature, stroma, solid tumor) and multicellular crosstalk of the tumor microenvironment. To determine the
impact of the metastatic site on modulation of PC phenotypes and lineage switching the Modeling Core will
perform experiments using MPS that recapitulate lymph node, liver and bone metastases.
Specific Aim 3. Generate defined genomic alteration in LuCaP cells lines and/or other PC cell lines for
detailed investigation of lineage plasticity. The Modeling Core will generate and distribute CRISPR
engineered cell lines that express pathological mutations found in patient populations. These cells will be used
for in vitro and in vivo investigations and in MPS to determine how these mutations contribute to lineage plasticity
and treatment resistance.
The Modeling Core is highly integrated with all three Projects and all Projects will rely significantly on the Core
resources and expertise.

Public health relevance
PROJECT NARRATIVE – MODELING CORE The Modeling Core will provide critical resources to all three P01 Projects to support the overall goals of identifying molecular drives of prostate cancer lineage plasticity and biomarker development. These resources include running preclinical studies in unique patient-derived xenograft (PDX) models and cell lines, modeling interactions between prostate cancer cells and metastatic sites using advanced microphysiological systems (MPS) and generating and distributing CRISPR-engineered cell lines with defined mutations and PDX-derived cell lines.